BIOLOGICAL DEFINITION OF HOST DEFENSE DEFECTS IN MAN

The pathogenesis of immunodeficiency diseases is being explored in our studies. Emphasis is on the genetic basis for these disorders. The influence of gene defects on the differentiation and function of immunocompetent cells is another key focus in these studies of immunodeficient patients.